Human Subjects Core

The broad, long-term objectives of the Massachusetts General Hospital/Harvard Medical School AADCRC entitled

Public health relevance
Allergic responses can be viewed as a state in which normal immune tolerance is lacking. It is our hope that our clinical studies involving allergen exposure in subjects with allergic asthma and milk allergy will lead to a better understanding of the role of T effector and T regulatory cells in allergic diseases and the mechanisms involved in lack of tolerance. We also hope our studies will provide novel insights into strategies for restoring immune tolerance, including manipulation of immune-tolerizing dendritic cells (DCs).